Aging impairs temporal fidelity in the auditory brainstem and underlies spatial hearing deficits

Project Summary
Hearing loss is one of the most common problems associated with normal aging. Sensorineural hearing loss,
caused by damage or loss of inner and outer hair cells and characterized by raised hearing thresholds in older
subjects, is well known and can be diagnosed through audiograms or otoacoustic emissions (OAEs). However,
there is a subtype of hearing loss known as central or “hidden” hearing loss that similarly affects aged
individuals. Hidden hearing loss is so termed because those afflicted present with hearing deficiencies, but
have normal audiograms; their hearing problems are therefore “hidden” from normal diagnostic measures.
Although subjects with hidden hearing loss have normal hearing sensitivity, they struggle to detect and
understand sounds presented above a background noise, and struggle with localizing sounds in space. The
underlying cause of hidden hearing loss is not currently well known, but because of the common symptoms of
decreased sound localization abilities with spared hearing thresholds, it is thought in part to arise from
dysfunction in the auditory brainstem. We hypothesize that hidden hearing loss in aging subjects is a result of
dysfunction in the auditory brainstem, specifically a mistiming of the inhibition arising from the medial nucleus
of the trapezoid body (MNTB). To test this hypothesis, we will perform auditory measurements in Mongolian
Gerbils, an animal model commonly used in binaural hearing research because of its hearing range similar to
humans and their ability to utilize interaural time differences (ITDs) and interaural level differences (ILDs) as
humans do. We will perform auditory measurements such as OAEs, audiograms, and monoaural and binaural
auditory brainstem responses (ABRs) and envelope following response (EFRs) to assess both the peripheral
hearing and binaural processing abilities of young and aged gerbils. We will also perform behavior tasks to
determine the spatial hearing abilities of these cohorts and correlate changes in behavior with potential
biomarkers of spatial hearing from our ABR results. Additionally, we will investigate if age-related dysfunction
arises from age-related changes directly to the auditory brainstem, a reduction of input from peripheral areas of
the auditory pathway, or both. To assess this, we will perform in vivo recordings from auditory brainstem nuclei
to directly measure the firing properties of neurons from the MNTB. We will also examine levels of cochlear
synaptopathy, a reduction in the synapses in the cochlea to the auditory nerve, in young and aging animals as
a metric of peripheral hearing ability. We expect to see a decrease of temporal fidelity of inhibitory neurons
from the MNTB in aging animals, which would correlate with an increase of cochlear synaptopathy, a reduction
of ABR waveforms confirming synaptopathy, and a decrease of spatial hearing performance in these animals.
Taken together, our electrophysiological, immunohistochemical and behavioral measurements will provide a
comprehensive understanding of the mechanism that drive age-related hidden hearing loss.

Public health relevance
Project Narrative Individuals 65 and older can suffer from central or “hidden” hearing loss, which makes localizing sound and detecting speech in noise difficult, but does not affect hearing in quiet environments. This type of hearing loss is difficult to treat because of our lack of understanding about the mechanisms that lead to this hearing loss. In this proposal, we will look at age-related changes in the auditory brainstem and cochlea that may correlate with a decrease in spatial hearing performance to better understand the mechanisms of age-related hidden hearing loss.